Admin Core

ADMINISTRATIVE CORE
SUMMARY
The Administrative Core benefits from the expertise of the entire administrative staff of
the Center for Visual Science, with the most significant responsibilities for administering
the Core falling on the PI and his Administrative Assistant. Both interact with other
members of the CVS Executive Committee, and the Core Directors and Associate
Directors in particular, to ensure efficient, cost-effective, fair, and scientifically optimal
use of the Technical Services of each of the three Cores.